Induction of Broad Sarbecovirus Immunity Via A Vaccine Engineered From SARS-CoV-2 Heptad Repeat 1

Project Summary/Abstract
Current COVID-19 vaccines fail to induce strong cross-reactive neutralizing antibodies against circulating SARS-
CoV-2 variants, which have undergone extensive mutation in the neutralizing epitopes of spike protein. Booster
vaccinations with variant-matched vaccines primarily strengthen immunity towards epitopes shared with the
original strain, leading to poor neutralizing activity against variants and failing to induce strong protection. This
biased immune response towards the ancestral strain is termed “original antigenic sin”. It results in repeated
infections with new variants regardless of vaccination status.
The overall goal of this proposal is to develop an improved SARS-CoV-2 vaccine that can induce broadly cross-
reactive neutralizing antibody responses against current and future variants by targeting a highly conserved
epitope in the heptad repeat 1 (HR1) region of the spike protein. When presented on spike protein, it is poorly
immunogenic and anti-HR1 antibodies rarely form naturally. Dr. Stampfer has developed an engineered antigen,
composed only of the HR1 epitope, that induces high titer anti-HR1 antibodies in mice. This immunogen also
functions as a scaffold when linked to an additional epitope, the receptor binding motif (RBM), which mutates
frequently between different SARS-CoV-2 variants and can induce very potent neutralizing antibodies. The HR1
portion of such a vaccine has the potential to induce broadly neutralizing antibodies against all variants, while
the RBM portion can function as a seasonal component targeting current circulating strains, all without boosting
non-neutralizing cross-reactive epitopes on spike protein. Three Aims are proposed. Aim 1 investigates the
immunogenicity and protection of the HR1 and RBM-HR1 vaccines against the current circulating SARS-CoV-2
variants in naïve mice, while Aim 2 evaluates their efficacy as boosters in mice with prior mRNA COVID-19
vaccination. Aim 3 will isolate vaccine-induced HR1-specific B-cells to generate broadly-active anti-HR1
monoclonal antibodies for prophylactic and therapeutic evaluation in mouse challenge experiments. Long term,
this lays the groundwork for future larger projects testing the optimized vaccine and anti-HR1 therapeutics in
nonhuman primates and humans, and in designing HR1-based vaccines for other viruses.
The research will be conducted at the Emory Vaccine Center, with multiple vaccinology labs whose close
proximity encourages new collaborations and the sharing of methodology and equipment, along with on-site
nonhuman primates for future preclinical vaccine testing. Dr. Stampfer’s career goal is to develop better
vaccines for viral pathogens by using protein structure data to design antigens that induce strong immunity to
critical epitopes. His career development plan includes hands-on training in vaccine development, neutralization
assays, and monoclonal antibody isolation, along with didactic and online courses in immunology, antibody
engineering, biostatistics, and grant-writing. The mentorship team of physician-scientists and viral vaccinologists
will ensure productive research and training, helping him launch his career as an independent researcher.

Public health relevance
Project Narrative COVID-19 vaccines are unable to prevent widespread infection with new viral variants, as even the updated vaccine tends to boost pre-existing antibodies to old strains instead of causing new antibodies to form against current strains. We designed a vaccine that causes antibodies to form to only one area on the virus: a weak spot that is identical in all strains. We will test and optimize this vaccine in mice, with the ultimate goal of using it in humans as a more effective booster vaccine against all viral strains.